Identification of proteins for breast cancer risk: an integrative epidemiologic and genomic study

Project Summary
Genome-wide association studies (GWAS) have identified over 200 genetic loci for breast cancer. To
translate these findings into an improved understanding of cancer biology, and thus, disease prevention and
treatment, it is essential to identify the target genes of these loci. However, causal genes (and the underlying
biological mechanisms) remain unknown for most of the GWAS-identified breast cancer risk loci despite recent
publications of transcriptome-wide association studies that have discovered a few putative causal genes.
Proteins, the final gene products, are key working molecules for cellular functions. Thus, proteins have a more
direct impact on disease risk than mRNAs. In addition, protein levels and mRNA levels are only moderately
correlated, with the median correlation being only 0.46, and for many genes, the correlation is close to zero.
Therefore, compared with investigating RNAs, directly investigating proteins may be more likely to reveal
causal genes and underlying biological mechanisms. We propose a novel proteogenomics study to identify
putative target proteins for breast cancer by capitalizing on multiple existing unique resources, 1) normal fresh-
frozen breast tissue samples from over 5,000 cancer-free women in the Susan G. Komen Tissue Bank (KTB);
2) proteomics and genomics data in 125 breast cancer tissue samples in the Clinical Proteomic Tumor
Analysis Consortium (CPTAC); and 3) GWAS data of ~ 427,000 breast cancer cases and controls from three
large consortia. We will conduct a well-powered proteome-wide association study (PWAS) by integrating
genomics and proteomics data in breast tissues in three racial groups (Aim 1). We will prospectively validate
the promising breast cancer risk proteins in pre-diagnostic normal breast tissues in a nested case-control study
including 120 incidence breast cancer cases and 480 individually matched controls (Aim 2). We will evaluate
the biological functions of the top breast cancer risk proteins by conducting a series of bioinformatics analyses
and in vitro functional assays (Aim 3). The proposed study will be conducted by an interdisciplinary
collaborative team of experts in breast cancer, epidemiology, genomics, proteomics, bioinformatics, and
biostatistics, with almost 20 years of collaboration. This proposed project is extremely cost-efficient because
breast tissue samples and the genomics data for Aim 1 will be available at no cost to this proposed study. The
proposed study is highly innovative as it is the first prospective breast tissue-based proteomics study and also
the first proteogenomics study by integrating genomics and proteomics data. Our study will be highly significant
and impactful by 1) unveiling the target proteins for future mechanistic research; 2) improving our
understanding of the genetic and biological basis for breast cancer; and 3) having important implications for
disease prevention and treatment for this common malignancy.

Public health relevance
PROJECT NARRATIVE We propose using exceptional resources and cutting-edge technologies to conduct the first proteogenomics study and the first prospective breast tissue-based nested case-control proteomics study to discover and validate breast cancer risk proteins. The biological functions of promising proteins will be further evaluated by a series of bioinformatics analyses and in vitro functional assays. Successful completion of this proposed study will unveil causal protein candidates for future mechanistic research, improve our understanding of the biological basis for breast cancer, and have important implications for disease prevention and treatment for this common malignancy.